NOMOCAN PHASE I - DEVELOPMENT OF THERAPEUTIC OR PREVENTATIVE TECHNOLOGIES FOR TREATMENT OR PREVENTION OF PEDIATRIC CANCERS AND/OR RARE CANCERS SBIR CONTRACTPHASE I - DEVELOPMENT OF THERAPEUTIC OR PRE

Pancreatic ductal adenocarcinoma (PDAC) is predicted to be the second leading cause of cancer-related deaths by 2030
with a 5-year overall survival rate is only about 13%. For the majority of PDAC patients with metastatic PC, the current
standard of care is systemic chemotherapy, which only extends survival by a few months. There is a critical need for less
toxic, more potent targeted therapeutics for PDAC. Details in Aims